Arsenite-induced necroptosis

Necroptosis is a recently identified caspase-independent cell death pathway that has
been shown to act downstream of death receptor signaling or virus infection. Virus infection can
be sensed by the host pattern recognition receptor, DAI, which leads to a cascade of events
leading to rapid explosive cell death, as a way to prevent virus replication. We have recently
shown that DAI not only senses virus infection, but also senses arsenite-induced stress, leading
to necroptotic cell death. This broadens the potential importance of DAI mediated necroptosis,
well beyond sensing of virus infection, to sensing of virus infection as only one example of stress
that can be sensed by DAI. This proposal will better characterize the role of DAI in sensing
stress and leading to necroptotic death, and will ask if this pathway is active in primary cells,
that have been linked to potential stress-induced necroptosis in vivo. As a developmental
proposal this work will justify a larger investment of resources in asking if stress-induced
necroptotic death is involved in neurodegenerative, and skin diseases, and in tissue damage
associated with ischemia and reperfusion.

Public health relevance
This proposal is the study of the relationships among the pattern recognition receptor DAI, virus- and toxin-induced stress, and human disease progression.